BLRD Research Career Scientist Award Application

PROJECT SUMMARY/NARRATIVE
The broad focus of Dr. Miller’s lab is to translate basic biology of aging into treatments to increase human
healthspan. Dr. Miller focuses on proteostatic mechanisms to increase stress resistance to slow aging and the
onset of chronic disease. These studies focus primarily on skeletal muscle to minimize age-associated loss of
muscle function (sarcopenia). These studies seek to preserve muscle function during aging by slowing the
insidious loss over time as well as aiding recovery after acute periods of rapid muscle loss such as during
hospitalization. The Veteran population is older than the general population and older Veterans have a higher
burden of comorbid chronic diseases compared to the general population, resulting in more frequent inpatient
hospitalizations. A consequence of frequent and recurring hospitalizations is the acceleration of age-related
loss of skeletal muscle mass and strength. The combined effect of sarcopenia and hospitalization exacerbates
muscle dysfunction since older Veterans do not adequately recover from bedrest, placing them on an
accelerated trajectory toward loss of independence. Dr. Miller has two Merit awards that focus on disuse
atrophy and periods after disuse to design interventions that aid in the recovery of muscle mass and function in
older individuals. One Merit focuses on key findings from the Miller lab that mTOR activity is high in aged
muscle and may lead to a loss of proteostatic maintenance because of high rates of protein synthesis. The
second Merit examines the role of mitochondrial energetics in facilitating the recovery of muscle after disuse.
This second Merit is also part of a Collaborative Merit, led by Dr. Miller, that brought together VA researchers
with diverse expertise that seek to develop interventions to improve recovery of muscle function after
hospitalization in aged Veterans. These efforts to support Veteran health are supplemented by four NIH R01
grants and a foundation grant (Hevolution) that all focus on maintaining muscle mass with age. This
productivity is made possible by the extensive collaborations Dr. Miller has established within the OKC VA,
with VA researchers in other states, and other non-VA funded collaborators. Dr. Miller is recognized for his
expertise as evident by positions as G.T. Blankenship Chair of Aging Research at OMRF, President of the
American Aging Association (AGE), and a Fellow of AGE, the Gerontological Society of America (GSA), and
the American Physiological Society (APS). Dr. Miller has served on study sections for the VA and NIH
(including a standing study section member) and is an Associate Editor for Journal of Gerontology-Series A,
and Geroscience, which are two of the highest impact aging journals. Dr. Miller has given over 100 invited
lectures, keynotes, and endowed lectures and has been featured on numerous podcasts for the general public.
Dr. Miller’s lab has focused on mentoring at all training levels. This mentorship is evidenced by being Co-PI on
an institutional training grant (T32), co-developing and co-directing a grant writing “boot camp” for CDA, F, and
K applicants that is run annually, achieving success in trainee fellowships and career development awards
within the lab, acting in service to numerous career development and training awards outside the lab, and
creating a junior faculty mentoring program in the Aging and Metabolism Research Program. Finally, Dr. Miller
has served the VA through study sections (national and local), local research committee positions (IACUC and
SRS), and through a research-focused “roundtable” at the OKC VA.

Public health relevance
PROJECT NARRATIVE Aging is associated with a gradual loss of muscle mass and function over time. Periods of hospitalization accelerate this progression because older individuals do not completely regain muscle mass and function after a period of disuse. This loss is particularly important for the aging Veteran population because they are at greater risk for hospitalization than the overall population and on average have longer hospital stays. Dr. Miller’s lab is known for its use of stable isotope tracers to study the remodeling of proteins to prevent age- related decline in muscle function. Through his VA and broader collaborations, the work in Dr. Miller’s lab integrates the translational spectrum to directly benefit Veteran health. In addition, Dr. Miller has worked extensively to train the next generation of researchers through one-on-one mentoring, developing mentoring programs, and leading courses.